Mechanistic modeling of the innate immune responses of the human lung to understand the inter-individual heterogeneity of COVID-19 pneumonia

PROJECT SUMMARY/ABSTRACT
A key feature of the COVID-19 infection is the vast inter-individual heterogeneity in the
severity of the infection. The complex biological mechanisms that underlie this variability remain
mostly obscure. We propose to provide a mechanistic understanding of this susceptibility by
leveraging 3 key innovations: First, we have developed a 3-dimensional lung culture system
that allows for detailed interrogation of the early events in SARS-CoV-2 infection. Second, we
have established an animal model of COVID-19 in mice transgenic for the human ACE2
receptor in our facility. Third, we have built a multi-scale mathematical model of lung infection in
COVID-19, that we now seek to expand and personalize to individual hosts. We have two Aims
in this project: In Aim 1, we will validate, expand, and personalize our existing multi-scale
model, using an unbiased approach to identify and test hypotheses relating to susceptibility to
severe COVID-19, and in Aim 2 we will test a specific hypothesis regarding the mechanism of
the observed inter-individual heterogeneity in COVID-19 severity, namely that it is, in part,
mediated by divergent activation of the mTOR pathway in type I alveolar epithelial cells. If
successful, this project will identify the biological basis of the immune pathways that result in
heterogeneous outcome of COVID-19, paving the way for personalized, host-specific
interventions to improve the outcome of the infection.

Public health relevance
PROJECT NARRATIVE COVID-19 is an ongoing global pandemic affecting many millions of people around the world. We currently have little understanding as to why some individuals develop a severe infection while most do not. This project seeks to achieve this understanding, and is relevant to public health because it can lead to better identification of at-risk individuals and more effective treatments for them.